A Single Dose Therapy to Treat Drug Resistant Gonorrhea

PROJECT SUMMARY / ABSTRACT
Gonorrhea is a sexually transmitted infection caused by N. gonorrhoeae. In recent years, the number of people
with gonorrhea infections in the US has steadily increased, with more than 700,000 infections reported in 2021.
N. gonorrhoeae has proven adept at acquiring resistance to every single antimicrobial therapy used for its
treatment in history, starting with the sulfonamides in the 1930s and then penicillin, tetracyclines,
fluoroquinolones, oral cephalosporins, and macrolides. In the past decade, there have been reports of strains
resistant to the last remaining recommended treatment, ceftriaxone. Thus, we are on the precipice of returning
to a pre-antibiotic era of untreatable gonorrhea. Left untreated, gonorrhea infections can cause serious or life-
threatening sequelae including infertility and ectopic pregnancy in women, and, if disseminated to the blood,
may lead to complicated infections resulting in cardiovascular and neurological problems. Further, vertical
transmission to neonates can lead to blindness or life-threatening bloodstream infections if not promptly
treated. In this Fast Track SBIR grant, we propose to develop an intramuscular (IM) injection formulation of an
innovative antibiotic, AMX-2005, as a first-in-class, single dose therapy for the treatment of drug-resistant
gonorrhea. A single dose regimen is currently the preferred therapeutic paradigm to treat gonorrhea by the
treating physicians and public health organizations such as the World Health Organization due to concerns
surrounding dosing compliance in some patients and the threat this poses to on-therapy resistance emergence
and continued spread of infection in the community. We believe that a single dose therapy is most likely
achieved with a non-oral antibiotic based on PK-PD considerations. AMX-2005 possesses numerous
microbiological attributes that are desirable as an antibiotic for the treatment of drug-resistant gonorrhea such
as lack of cross-resistance to other antibiotics (including high-level ceftriaxone- and azithromycin-resistant
strains), low potential for resistance development (spontaneous mutation frequencies <5.6x10-10 CFU/mL), and
rapid bactericidal activity, including against intracellular N. gonorrhoeae. A single IM injection of a protype
formulation of AMX-2005 has demonstrated efficacy in a vaginal model of gonorrhea infection in mice
comparable to the current gold standard ceftriaxone. These proof-of-concept data highlight the potential of
AMX-2005 to address the urgent threat posed by the possible dissemination of strains resistant to all currently
available antibiotics and advocate for rapid development of injectable AMX-2005. In this grant, we plan to
optimize/manufacture the IM formulation, perform IND-enabling safety evaluations, and obtain necessary
pharmacokinetic data leading to an IND application for IM AMX-2005 to commence the first human clinical trial.

Public health relevance
Project Narrative Antibiotic resistance in Neisseria gonorrhoeae is an urgent public health crisis requiring immediate action towards identifying new therapies without cross-resistance to existing antibiotics. Effective single dose therapies result in a faster resolution of symptoms and can significantly reduce the risk of spread of the infection in the community. We are developing a single-dose regimen of the novel antibiotic, AMX-2005, to rapidly treat drug-resistant gonorrhea.